Gnotobiotics, Microbiology and Metagenomics Core

Project Summary:
The Gnotobiotics, Microbiology and Metagenomics Core (Core D), supports investigators studying
functional roles of the microbiota in health and disease. Core D has supported >100 groups interested in
evaluating mechanisms of action by which the host’s microbiota affects host physiologic and
pathophysiologic processes.
Our resources include a Microbiology Unit for microbiologic culturing, phenotyping, analysis of primary
samples for microbial metabolite profiles, and develop defined consortia for functional studies, a Clinical Lab
(CLIA) Unit to support microbiome-focused clinical trials, a Molecular Unit for sequence-based analyses, a
Gnotobiotic (germfree) mouse facility for in vivo studies in animal models, a Metabolic Unit to support
mouse metabolic cage, body composition and metabolism studies, and a Computational Unit which
undertakes novel algorithmic development to evaluate longitudinal dynamics of the microbiota and assist
users in experimental design for host-microbiota studies.
Core D provides support to multiple academic centers in the greater Boston area.